ELECTRON PARAMAGNETIC RESONANCE SPECTROMETER

Funds are requested to purchase an EPR spectrometer to be housed in the Magnetic Resonance Instrumentation Laboratory of the Department of Chemistry at Harvard University. We seek to acquire a modern, computer- driven instrument that is accessible to a group of users with a wide-range of expertise in EPR spectroscopy, but nonetheless a research-grade instrument capable of meeting the full needs of the users group. The requested EPR instrumentation includes a Bruker ESP-series spectrometer equipped with the necessary components for operation at X-band and Q-band, as well as the associated cryogenic equipment for operation at sample temperatures from 2 K to ambient temperature. This instrument will be utilized to advance a number of research projects of biological and biomedical interest: bioinorganic chemistry of iron-sulfur clusters; spin- label studies of biomolecular interactions and interfaces; biochemical studies of EDRF and the effects of nitrosothiols on vascular and platelet function; EPR studies in support of high-field EPR and DNP experiments; and EPR studies of the structure of ras-p21 proteins.